Cytoskeletal organization by Toll-like receptors during epithelial morphogenesis

Cell fate and behavior are controlled by spatially and temporally regulated extracellular signals that are
recognized by transmembrane receptors at the cell surface and relayed by cytosolic effectors to distinct locations
within the cell. Disruption of receptor signaling can alter cell behavior and lead to developmental defects and
diseases such as cancer. The Toll-like family of receptors signal to effectors that activate NF-κB and MAP kinase
signaling to induce transcriptional changes required for innate immunity. By contrast, Drosophila Toll-related
receptors have been shown to activate a localized tyrosine kinase signaling cascade through the activation of
Src family nonreceptor tyrosine kinases, which recruit effectors that elicit spatially regulated changes in the
activity of the actomyosin cytoskeleton. However, the effectors downstream of Toll receptor-mediated tyrosine
kinase signaling that regulate actomyosin dynamics and cytoskeletal organization to promote polarized cell
movements in the Drosophila embryo are not known. In this proposal, I will identify effectors that link Toll receptor
signaling to actin regulators during axis elongation in the Drosophila embryonic epithelium and determine how
these regulators contribute to spatiotemporally regulated actomyosin contractility and cell behavior. In Aim 1, I
will analyze the dynamic localization of regulators of the actin cytoskeleton and actomyosin contractility and
determine how they affect the rapid reorganization of cell polarity and behavior. In Aim 2, I will determine how
these factors promote epithelial remodeling by characterizing how they affect the intracellular assembly of
signaling complexes and their genetic and biochemical interactions with upstream regulators of actomyosin
contractility. In Aim 3, I will investigate how components involved in cytoskeletal organization are
spatiotemporally regulated at the cellular and molecular level and how these processes influence the dynamic
signaling events that organize cell polarity and behavior. The proposed studies will take advantage of in vitro
biochemistry and in vivo genetic tools, quantitative live imaging analysis, and super-resolution microscopy to
understand how cell-surface receptors communicate with the actomyosin cytoskeleton to effect collective
changes in cell polarity and behavior during embryonic development.

Public health relevance
The Toll-like family of receptors have diverse roles in innate immunity, developmental patterning, and tissue morphogenesis. In contrast to the long-term effects of these receptors on gene expression, how these receptors induce rapid changes in cell shape and behavior during epithelial morphogenesis is not well understood. This proposal aims to uncover the mechanisms that transmit signals from active Toll-like receptor complexes to the actomyosin cytoskeleton in the Drosophila embryo, which could be relevant to understanding how cell-surface receptors direct cell behavior in other developmental contexts.